City of Hope Clinical Oncology Career Research Development Program

Abstract
The Paul Calabresi Career Development Award for Clinical Oncology (K12 Program) at the City of Hope
Comprehensive Cancer Center has been funded for more than 25 years. The overarching goal of the K12
Program is to develop a new generation of clinical oncology investigators capable of translating basic
advances in cancer biology into novel strategies for the diagnosis, therapy, and prevention of malignant
disease. To this end, the K12 Program provides a structured, multidisciplinary approach to training and
mentoring junior faculty to ensure their success as clinician researchers and leaders in cancer research.
Eligible candidates are within five years of completing their training and are selected from a variety of
specialties. The Principal Investigator/Program Director, Associate Director, Program Administrator/Curriculum
Director, and seven faculty members constitute the Advisory Committee. This Committee selects the Scholars,
regularly assesses their academic progress, and provides input on the curriculum. Annually, two external
advisors evaluate the overall program and the progress of the current Scholars. The four-year K12 Program
begins with the year-long Clinical Investigator Training Program, which provides structured coursework in
topics including study design, statistics, team building, protocol writing, good clinical practice, responsible
conduct of research, and grant writing. Practical skills training in leadership and data presentation are
incorporated throughout the four years. Each Scholar identifies a clinical and laboratory mentor who provide
support throughout the Scholar’s completion of a translational research project, for which they are guaranteed
protected time. The Scholars meet quarterly with the Advisory Committee and formally present their research
progress biannually for critique and input on their progress. The Program Director and Associate Director meet
individually with the Scholars on a quarterly basis to review the critiques of the Advisory Committee and to
provide Scholars with the opportunity to troubleshoot any problems or barriers to their career development.
Scholars are also encouraged to provide suggestions for program improvement. The K12 Program continues
to evolve with the addition of new mentors and enhancements to the curriculum. Participation in the program is
considered prestigious by both the Scholars and their mentors. The value of the K12 Program is evident in the
success and productivity of our Scholars. The nineteen K12 Scholars enrolled in the past 10 years have
produced 853 publications, 227 of which are first-author publications, and 199 of which are senior-author
publications. They have been awarded 109 grants including three NIH R01s, an NIH R03, an NIH R21, four
other NIH grants, 25 foundation grants, and 75 others. Eighteen of the nineteen Scholars continue as
academic faculty and all have been promoted or are in the process of being promoted to the level of Professor
or Associate Professor, emphasizing the ability of our program to train independent clinical investigators.

Public health relevance
NARRATIVE The goal of the K12 Career Development Program at City of Hope is to provide a structured, multidisciplinary approach to training junior faculty to become independent investigators capable of translating advances in molecular oncology to the bedside and back. K12 Scholars engage in a multidisciplinary curriculum with didactic, laboratory, and clinical experience components in basic, translational, and clinical research in cancer- related fields. Scholars are guaranteed protected time for mentored translational research, and each is mentored by a clinician-scientist and a laboratory researcher.